Estrogen and glucocorticoid receptor crosstalk in ER+ breast

PROJECT ABSTRACT
Approximately 70% of invasive breast cancer expresses estrogen receptor-alpha (ER). Our lab and others
have found that 50-60% of early-stage ER+ breast cancers also express glucocorticoid receptor (GR), and that
high GR expression provides favorable prognostic information in early-stage breast cancer independently of
PR expression. Specifically, in an analysis of primary tumor GR expression in ER+ invasive breast tumors from
over 1000 ER+ early-stage patients with >20 year clinical follow-up, we discovered that high tumor GR mRNA
expression (and by implication, high GR activity) was associated with a significantly lower risk of relapse. More
recently, we found that in ER+ breast cancer cell line models, GR activation remodels chromatin so that ER-
chromatin association and ER-target gene expression are significantly altered. Based on these data, we
hypothesize that ER and GR can provide coordinated regulation of good prognosis, anti-proliferative and pro-
differentiation genes. We propose to determine the molecular mechanisms underlying GR-mediated
modulation of both wild-type and mutant ER transcriptional activity, and to define the specific patterns of
ER/GR-mediated gene expression in breast cancer. In Aim 1, we will characterize how GR ligand binding
domain activation [by either dexamethasone (dex) or novel selective GR modulators (SGRMs)] affects ER
activity, consequent ER-mediated gene expression, and ultimately ER-associated tumor cell proliferation. In
Aim 2, we will investigate GR and ER chromatin and co-regulator association in the presence of dex in
comparison to the novel SGRMs. This will allow us to better understand the requirements of chromatin
conformation and GR/ER co-regulator assembly in modifying ER+ breast cancer's proliferative gene
expression. Finally, in Aim 3, we will use in vivo ER+ breast cancer patient-derived xenograft models, mutant
ER-expressing cell lines, and tamoxifen-resistant ER+ models to define SGRM anti-tumor activity with the aim
of defining clinical contexts in which GR modulators are most likely to be effective. Together, these
experiments will both increase our understanding of GR/ER crosstalk in breast cancer (and possibly other
hormone-sensitive cancers e.g. endometrial) and are expected to lead to new GR-targeted therapies that
harness our discovery of anti-proliferative activity following GR modulation in ER+/GR+ breast cancer.

Public health relevance
PROJECT NARRATIVE One of the most pressing problems in breast cancer treatment is to devise new therapies for estrogen receptor-expressing tumors that do not respond adequately to anti-estrogen therapies. For these tumors, our laboratory discovered that a related hormone receptor, the glucocorticoid or stress hormone receptor, can also be targeted to help reduce tumor growth driven by estrogen. In this project we will perform experiments to understand the mechanisms whereby these two hormone receptors act in breast cancer, with the overall goal of developing new, effective and relatively non-toxic treatments for breast cancer.